Center for Quantitative Biology Administrative Core

PROJECT SUMMARY
A responsive and proactive Research Administration and Mentoring Core is critical to the successful operation
of any large and complex research program, center, or institute. The overall goal of the Research Administration
and Mentoring Core is to provide leadership and general administration related to all aspects of the Center for
Quantitative Biology (CQB) COBRE. The central responsibilities of the Research Administration and Mentoring
Core are to oversee the mentoring and development of junior COBRE investigators (Aim 1). The Research
Administration and Mentoring Core will also be responsive and proactive to the needs of the CQB - COBRE by
providing administrative, organizational, grant preparation, communication, and financial management support
to COBRE leadership, project leaders, newly recruited faculty, mentors, and cores (Aim 2). This core will also
be responsible for managing and evaluating all project and core resources. The core will secure meaningful
external evaluations, ensure regulatory compliance, and meet milestones, including timely communication and
consultation with project officers (Aim 3). Finally, the core will be responsible for convening all meetings, including
monthly meetings of the COBRE leadership, Research Project Leaders, Pilot Project Leaders, Mentors and Core
leadership, as well as the annual in-person meetings of the Advisory Committee (AC).